NMRbox: Bayesian Analytics

Abstract: TRD 3. Nuclear magnetic resonance spectroscopy (NMR) is a powerful analytical
instrument with numerous applications in biomedicine. Some examples of high-impact
investigation are studies using metabolite profiles as markers of health status, evaluation of
small molecules for biological activity as a drug, and discovery of new metabolic compounds.
NMR offers detailed information, but the interpretation of data involves a multistep process that
often involves using data from other analytical instruments. The use of a range of sophisticated
mathematical and computational methods is required, and this is often a major bottleneck. The
aim of this TRD is to deliver enhanced functionality for robust and reliable statistical framework,
based on Bayesian principles. This project will advance the state of NMR data analytics and
simplifies the future development of advanced NMR applications. Central components of this
TRD include a Bayesian inference engine, tools for validation of experimental models and
results, a set of programming interfaces, and a library of templates for facilitating the
identification of metabolite and small molecule signatures in biological mixtures. The
implementation of this TRD will benefit from key advantages offered by the NMRbox platform.
By facilitating the deployment, utilization, interoperation, and persistence of this advanced
technology, the proposed TRD will advance the application of NMR for a wide range of
challenging applications in biomedicine and helps ensure the reproducibility bio-NMR studies.